Research Education Component

Abstract Research Education Component (REC)
The REC serves as the research education component and pilot studies core. The REC core
serves as the central components scientific training of our Center for Health Equity in
Cognitive Aging – Joining Population Science and Health Promotion (CHECA) Scientists.
The REC will be responsible for identifying priority topic areas for targeting pilot research that
are consistent with the thematic foci CHECA (Aim 1), and soliciting the call for pilot studies,
peer-review, and selection of the top CHECA Scientists (Aims 2 and 3). The REC will provide
support to CHECA Scientists and CHECA mentors (Program Faculty) and provide continuous
monitoring of ongoing pilots studies (Aim 4). The REC will serve as the primary mentorship
component of CHECA and has developed a core set of workshops for the each CHECA cohort.
The REC further guides the development of the IDP (personalized education plan), career
development, and networking opportunities (Aim 5). CHECA will be multidisciplinary with
diverse mentors bridging across disciplines and provides support in RCMAR Scientists’ home-
departments and will incorporate mentor and mentee training on diversity, equity, inclusion, and
adaptation (Aim 6). The pilot awards are funded up to $50,000 for one year and should be
designed to collect preliminary data in support of a K-award or an R-level grant. RCMAR
Scientists received guidance and mentorship via individualized mentoring plans. The unique
needs of URM CHECA faculty Scientists will be addressed using a mentor and cohort model.
We will develop an individualized mentoring program that will provide needed social support and
optimize the use of existing campus support resources as well as identity gaps in those
resources and work to fill them. We will work with each RCMAR Scientist to improve
communication skills and time management. Mentors will provide psychosocial support
functions, (e.g., emotional support and role modeling. The CHECA REC program includes the
following cohort components: 1) Orientation bootcamp during which they will be connected with
content mentors and the analyses core. 2) Mentor guided individual development plan. 3)
Development workshops and grant writers' groups. 4) Networking opportunities. 5) Mentor
development workshops.